Role of the NLRP3 Inflammasome in Mediating Microglial Activation and Development of Neuropsychiatric Symptoms Induced by HIV, Antiretrovirals and Cocaine

Abstract
Although people living with HIV (PLWHIV) have comparable life-expectancy as the HIV-negative population
does, their life-quality is still deeply compromised due to the prevalence of neuropsychiatric disorders including
depression and anxiety. The main pathological changes in the brains of those people include aberrant microglial
(Mg) activation and neuronal injuries. Drug abuse is a high comorbidity of HIV infection and abused drugs could
exaggerate the existing neurologic complications in PLWHIV. The detailed mechanisms underlying such
phenomenon remain much elusive. Several contributing factors have been suggested for such neurological
disorders including the continued expression HIV proteins such as trans-activator of transcription (TAT), the
long-term use of antiretrovirals (ARVs), and drugs of abuse. Our preliminary data demonstrated that :1) NLRP3
inflammasome signaling was involved in HIV-TAT-mediated Mg activation; 2) cocaine activated Mg through
dysregulating miR-124/TLR4 axis, which could be reversed by inhibition of NLRP3 inflammasome; 3)
combination ARVs used in clinical practice (tenofovir:TFV, emtricitabine:FTC, and dolutegravir:DTG) could
activate Mg via lysosomal dysfunction; 4) co-exposure of Mg to three agents (TAT, cocaine, and ARVs)
intriguingly resulted in increased activity of NLRP3 inflammasome in vitro; 5) IL1β, the final executor of NLRP3
inflammasome activation, decreased the spine density and increase the glutamate receptor ionotropic NMDA
subunits (Grins) in vitro; and 6) increased NLRP3 inflammasome activity was shown in the brains of SIV-infected
macaque. Based on these findings and two distinct steps of NLRP3 inflammasome activation, we hypothesize
that exacerbated NLRP3 inflammasome activation in the context of HIV-TAT/HIV, cocaine, ARVs will lead to
exaggerated Mg activation and neuronal injuries, which are responsible for the high incidence of neuropsychiatric
disorders in PLWHIV with cocaine use. We will test this hypothesis in the following two specific aims (SA) using
complimentary in vitro and in vivo approaches. SA1: Investigate the role of NLRP3 inflammasome in Mg
activation and neuronal injuries in the context of HIV-TAT/HIV, cocaine, & ARVs. We will split this SA into three
sub aims. SA1A will explore the detailed mechanisms responsible for exaggerated NLRP3 inflammasome
activation in vitro; SA1B will explore the mechanisms underlying NLRP3 inflammasome-mediated neuronal
injuries; and SA1C will investigate the status of NLRP3 inflammasome and neuronal injuries in archived SIV-
infected macaque brains and HIV-infected individuas with or without cocaine use. SA2: Explore the potential
therapeutic effects of NLRP3 inflammasome inhibition on neuropsychiatric behaviors in HIV iTat mice in vivo.

Public health relevance
Narrative People living with HIV have comparable life-expectancy as their HIV-negative peers but their life-quality is deeply compromised due to the high prevalence of neuropsychiatric disorders. Cocaine abuse could exacerbate the existing neurological disorders in PLWHIV. Understanding the detailed mechanisms for the combined effects of HIV/HIV-TAT, antiretroviral and cocaine on microglial activation and neuronal injuries could give us clues to develop effective therapeutics and interventions for those people.